Early Detection and Treatment of Hematopoietic Stem Cell Transplant-Associated Thrombotic Microangiopathy (HSCT-TMA)

PROJECT SUMMARY/ABSTRACT
Hematopoietic stem cell transplant-associated thrombotic microangiopathy (HSCT-TMA) is a common
and often devastating condition following allogeneic hematopoietic stem cell transplantation, causing injury to
small vessels, particularly in the kidney. HSCT-TMA occurs in 13-40% of patients post-HSCT, and is
associated with a considerably higher risk of kidney replacement therapy (KRT) and death. There is a dire
need to identify early markers of HSCT-TMA, as well as treatments to prevent morbidity and mortality.
In Aim 1, we will examine whether markers of endothelial injury and complement overactivation are early
predictors of HSCT-TMA. We will leverage Dana-Farber Cancer Institute’s Pasquarello Sample Bank, which
contains plasma and serum samples from >3000 adult allogeneic HSCT patients. In a nested case-control
study, we will obtain serum from 50 adults with HSCT-TMA and 50 without HSCT-TMA. Samples will be
obtained prior to HSCT and at day 7 following HSCT. In Aim 1A, we will examine whether baseline-adjusted
markers of endothelial injury (von Willebrand factor, soluble fms-like tyrosine kinase 1, and thrombomodulin)
are elevated at day 7 in patients with vs. without HSCT-TMA. In Aim 2A, we will test for complement-mediated
cell death in patients with vs. without HSCT-TMA at the same time points using the modified Ham test (primary
exposure), a validated, cell-based assay, in collaboration with hematologists at Johns Hopkins with expertise
performing this test. We will also measure other markers of complement activity (annexin 2, factor D,
properdin, complement factor H) at each time point as secondary exposures.
In Aim 2, we will examine whether treatment with eculizumab, a terminal complement inhibitor, is
associated with improved renal and overall outcomes in patients with HSCT-TMA. Using data from >12,000
patients treated with HSCT at 4 major cancer centers, we will test whether early treatment of HSCT-TMA with
eculizumab (i.e., within the first month of diagnosis) is associated with a lower risk of KRT or death compared
to later or no treatment with eculizumab. We will apply the principles of target trial emulation to address
common biases in observational studies.
This proposal builds upon the PI’s expertise in onconephrology and expands on newly-obtained skills in
biomarker and causal inference analyses. It also proposes a new direction focused on HSCT recipients, who
are at high risk for kidney-related complications. The results of the proposed projects will have important
implications for HSCT-TMA, as they will lay the foundation for larger prospective studies designed to develop
and validate a larger panel of predictive markers, and for randomized clinical trials testing the efficacy of
therapies for HSCT-TMA.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell transplant-associated thrombotic microangiopathy (HSCT) is a common and devastating complication of allogeneic HSCT that is associated with considerable morbidity and mortality; however, biomarkers for early detection of HSCT-TMA and effective therapeutic strategies are lacking. In this proposal, we will examine whether markers of endothelial injury and complement overactivation are early predictors of HSCT-TMA. We will also use a target trial emulation framework to test whether a therapeutic strategy of early complement inhibition with eculizumab improves outcomes in patients with HSCT-TMA.